Vanderbilt-Ingram Cancer Center SPORE in Gastrointestinal Cancer

PROJECT SUMMARY/ABSTRACT: Overall
This application is an A1 submission of the Vanderbilt-Ingram Cancer Center Gastrointestinal SPORE, which
will focus on colorectal cancer, the second leading cause of cancer-related deaths in the United States. Our
potential for success is high based on 1) productivity during the previous cycle of the GI SPORE, 2) exceedingly
strong institutional support, 3) recruitment of talented investigators to the field of GI cancer through career
enhancement and developmental research funding, 4) access to unparalleled resources for drug discovery and
ex vivo models, 5) a blend of young and seasoned clinical investigators and basic scientists working together in
a highly collegial environment, 6) a committed group of patient advocates now organized into a patient advocacy
council and 7) multiple inter-SPORE, pharmaceutical, national and international horizontal and vertical
collaborations. We narrowly missed being funded on our A0 submission and have been provided interim funding
by NCI. We propose three projects and four supporting cores.

Public health relevance
PROJECT NARRATIVE: Overall The Vanderbilt-Ingram Cancer Center GI SPORE continues to focus on colorectal cancer, the second leading cause of cancer-related deaths in the United States. Building upon our past success and leveraging institutional resources and support, we propose three projects that aim to develop and deploy small molecules against two supposedly undruggable targets that drive colorectal cancer, MYC and β-catenin, as well as overcoming immune exclusion in individuals with microsatellite stable colorectal cancer that makes up 85% of colorectal cancer and these individuals do not respond to immunotherapy. We aim for practice-changing approaches to the diagnosis and treatment of colorectal cancer.